Pathobiology of Nonalcoholic Steatohepatitis

PROJECT SUMMARY/ABSTRACT
The long-term objective of this application is to define the molecular and cellular mechanisms that drive the
pathogenesis of nonalcoholic steatohepatitis (NASH), with the goal of identifying therapeutic strategies. NASH
is a progressive form of nonalcoholic fatty liver disease characterized by sublethal hepatocyte lipotoxicity (i.e.,
toxic lipid-induced cellular stress, which does not induce cell death) and consequent liver tissue inflammation.
The overall objective of this proposal is to examine: (a) how sublethal lipotoxicity in hepatocytes triggers the
release of extracellular vesicles (EVs) to augment liver immune infiltration by pathogenic CD4+ T helper cells;
and (b) how these abnormal processes during NASH can be therapeutically reversed. To this end, we have
made several pivotal observations. First, we found that sublethal lipotoxicity in hepatocytes activates Rho-
associated protein kinase (ROCK) 1 by a caspase-6-dependent mechanism. Moreover, genetic ablation of
ROCK1 specifically in hepatocytes attenuates NASH-associated liver injury and fibrosis in mice.
Mechanistically, ROCK1 is critical for the release of lipotoxicity-induced EVs and their enrichment in activated
leukocyte cell adhesion molecule (ALCAM), a ligand for the CD6 receptor expressed by CD4+ T cells.
Consistent with ALCAM enrichment, hepatocyte-derived lipotoxic EVs significantly enhance migration of CD4+
T helper cells in an ALCAM-dependent manner. Finally, activated CD4+ T cells are enriched in NASH livers,
and their depletion attenuates murine NASH. Based on these preliminary observations, we propose the
CENTRAL HYPOTHESIS that sublethal lipotoxic signals induce ROCK1 activation in hepatocytes, which
results in the release of pathogenic EVs that promote CD4+ T cell-mediated hepatic inflammation during
NASH. We will now employ in vitro experimental approaches, animal models, and human biospecimens to
examine the HYPOTHESIS in three integrated SPECIFIC AIMS. First, we will test the hypothesis that
sublethal lipotoxicity activates ROCK1 through: a) an incomplete mitochondrial outer membrane
permeabilization; and b) non-lethal proteolytic activity of caspase-6. Second, we will investigate how sublethal
lipotoxicity in hepatocytes results in: a) the release of ALCAM-bearing EVs; and b) the stimulation of CD6
receptor expressed on CD4+ T helper cells, leading to their recruitment into the liver. Third, we will test the
hypothesis that in a murine model of NASH: a) CD6 inhibition attenuates NASH by preventing CD4+ T cell
infiltration of the liver; and b) specific ROCK1 inhibition reverses NASH progression. Finally, the human
disease relevance of our findings from the preclinical studies will be assessed using well-annotated human
liver tissue specimens. This technically and conceptually innovative application is also significant because
it provides mechanistic insights into hepatocyte-to-CD4+ T helper cell crosstalk in NASH, thus identifying viable
therapeutic interventions, such as inhibition of ROCK1 kinase activity or CD4+ T cell-associated CD6 receptor.

Public health relevance
PROJECT NARRATIVE/ LAY SUMMARY This application examines the mechanisms by which nutrient excess and obesity cause liver damage with tissue inflammation and scarring. We propose that liver fat accumulation stimulates pro-death signaling cascades, thereby causing liver cells to release molecules that induce inflammation via the invasions of white blood cells and that inhibition of these processes prevents liver injury and its sequelae. The results of these preclinical studies are germane to mechanisms of liver injury in the common syndrome of nonalcoholic fatty liver disease and have the potential to identify new therapeutic strategies for treating human liver disease.